Novel strategies for defining the role of HLA in SLE

DESCRIPTION (provided by applicant): We propose to define the complex role of genes within the major histocompatability complex (MHC) region on chromosome 6p21 in systemic lupus erythematosus (SLE) pathogenesis. Our study design is based on the overall hypothesis that complex genetic and non-genetic MHC related mechanisms, including effects conferred by classical HLA loci, contribute to both disease risk and clinical outcome. It is clear that the genetic contribution of the MHC to SLE is substantial, with HLA class II genes demonstrating the most prominent association. However, the extensive linkage disequilibrium in the region and incomplete knowledge of allelic variation in surrounding genes has been a major limiting factor in attempts to further define the genetic contribution of the MHC to SLE. Through the recent efforts of the MHC Haplotype Project, all genes encoded within the approximately 4.5 Mb MHC region have been identified and localized, and are now publicly available, providing an unparalleled molecular guide for deciphering the MHC contribution to SLE. It is also evident that additional mechanisms such as genomic imprinting and non-inherited or environmental influences are likely to be involved in susceptibility to complex diseases such as SLE. Using 1,000 stringently ascertained and clinically characterized SLE families, state of the art genotyping methodologies, and novel analytical approaches we propose for the first time a comprehensive study of all genes residing within the MHC. In addition, we will investigate potential imprinting and maternal-fetal relationships in these families to determine whether MHC encoded loci and specific HLA alleles or haplotypes influence the risk of SLE. These studies will unequivocally identify the genes and allelic variants residing in the MHC region involved in susceptibility to SLE. Further, due to the strong relationship of lupus nephritis to SLE morbidity and mortality, in conjunction with data supporting distinct genetic associations with this outcome, we will study lupus nephritis as an important secondary outcome.